Improving Inflammation Resolution to Mitigate Acquired Bone Marrow Failure

Improving Inflammation Resolution to Mitigate Acquired Bone Marrow Failure
Bone marrow failure is the devastating collapse of blood production, and current treatments are
inadequate. First line therapies include immunosuppressive therapies, and when feasible, bone marrow
transplantation. These therapies are often efficacious in the short-term, especially for young patients,
however they are much less effective in older patients. Immune suppression is not well tolerated,
especially in the elderly, and carries increased susceptibility to infection. Therefore, alternative
therapies are needed. It is well established that bone marrow failure is associated with non-resolving
inflammation. The resolution of inflammation requires the balance between pro-inflammatory
leukotrienes or prostaglandins and w3-derived specialized pro-resolving mediators (SPMs), like
resolvins. Using a mouse model of acquired severe aplastic anemia (SAA) that mirrors key features of
human disease, we established a role for impaired inflammation resolution programs in disease
pathogenesis. Our preliminary work demonstrates the effectiveness of SPMs in ameliorating SAA. The
rationale for the proposed work is that rather than blunting inflammatory responses, promoting
resolution and reparative processes may be an ideal therapeutic strategy for bone marrow failure. The
proposed studies will address a fundamental gap in our understanding of the physiologically relevant
process of inflammation resolution in the bone marrow. We propose three integrated, but independent,
Aims to: (1) address mechanisms of impaired resolution, (2) determine the impact of SPMs in the
marrow in SAA, and (3) evaluate the effect of SPMs on function of hematopoietic stem cells.
The proposed work will support a novel approach to treat BMF without the use of immune suppression,
representing an important departure from the current standard of care. We believe these studies will be
impactful therapeutic options for BMF patients, particularly older patients where IST has failed, and
wherein host defenses are already weakened. At the same time, the proposed studies may provide
new mechanistic insight relevant to other diseases characterized by prolonged and non-resolved
inflammation, and thus will have broad impact to human health.

Public health relevance
Narrative Bone marrow failure syndromes are fatal if untreated and current therapies and strategies that prolong and improve survival outcomes are desperately needed. We will investigate how improving inflammation resolution programs can be leveraged as a new therapy for treating bone marrow failure. Our work is relevant to the part of NIH’s mission that pertains to seeking fundamental knowledge about the behavior of living systems to enhance health, lengthen life, and reduce the burdens of illness.